Dissecting Lung Spatial-Biological Niches in Early Fibrogenesis

PROJECT SUMMARY
Interstitial lung diseases (ILDs) represent a global clinical burden that affects >5,000,000 people. Commonly,
ILDs have no clinically determinable cause and are diagnosed as idiopathic pulmonary fibrosis (IPF), which
presents a median survival time of only 2-4 years after diagnosis. Given the unclear pathogenesis of many ILDs,
there is a strong clinical need to elucidate biological mechanisms that contribute to their onset and progression.
Interestingly, ILDs often exhibit a heterogeneous distribution of (1) healthy tissue regions, (2) early-fibrogenic
foci, and (3) mature-fibrotic tissue, each of which presents a unique cellular/biochemical milieu, tissue
architecture, and response to therapy. Traditional biological analyses of ILDs, including single-cell RNA
sequencing (scRNA-seq) and other omic-scale methods, have mostly generated composite molecular profiles,
which may mask important distinctions between foci such that pathological vs. ameliorative states cannot be
directly inferred. This project aims to disaggregate early-fibrogenic microenvironments in an ILD-specific manner,
uncovering highly resolved cellular/molecular drivers specific to early scar progression. Further, therapeutic
testing for ILDs has similarly centered on (1) in vitro models devoid of spatial-biological context and/or (2) bulk
treatment of murine lungs, which may obscure intra-tissue variability in the effects of treatment based on local
niche. The overarching goals of this proposal are therefore to spatially profile and recapitulate disease/foci-
specific “neighborhoods” that specifically drive early fibrogenesis using spatial biology and biomaterial modeling.
Overall, this project seeks to shift current paradigms by utilizing spatial-biological data as an anatomical
“blueprint” for disease- and niche-specific modeling of early fibrogenesis, enabling unprecedented detail
in dissecting the contributions of in situ tissue context to the initiation of scarring across multiple ILDs.
Specialized fibroblast phenotypes play a critical role in the fibrosis of all major organs. Based on prior studies, I
hypothesize that fibroblast-centered neighborhoods differentiate healthy vs. early-fibrogenic vs. mature-fibrotic
tissue regions across human ILDs. Specific Aim 1 will profile ILD-specific foci by integrating (1) machine learning
(ML)-based tissue architecture analysis with (2) high-plex immunofluorescence. Specific Aim 2 will recapitulate
fibrogenic cell-matrix interactions by using light-catalyzed bioconjugation chemistry to generate user-defined
extracellular protein patterning in two model systems. Specific Aim 3 will dissect fibrogenic cellular crosstalk by
using 3D bioprinting to recapitulate niche-associated cell-cell interactions (i.e. endothelial cells with specialized
fibroblasts). Ultimately, this project will integrate ML, spatial biology, and biomaterials modeling to elucidate the
roles of localized biological niches to the onset of scarring across ILDs.

Public health relevance
PROJECT NARRATIVE Interstitial lung diseases affect >5,000,000 patients globally and often result in a mixture of (1) healthy tissue, (2) early scar tissue, and (3) mature scars – even within the same patient. Each of these different types of tissue has a unique assortment of cells and proteins, but traditional biological methods that examine lung tissue in bulk cannot distinguish the factors unique to each tissue type. This project examines how the cell/protein composition of early scar regions differs from both healthy tissue and mature scars, enhancing our understanding of the onset of scarring and our ability to target early disease progression.